Advancing Cancer Screening and Prevention Trials at the University of Colorado Cancer Center

The University of Colorado Cancer Center (UCCC) is the only NCI-designated Cancer Center in Colorado serving
a primary catchment area of the State of Colorado. The vision of UCCC is to prevent and conquer cancer.
Together. Dr. Wood joined the faculty and UCCC in 2021. She is a leader in cancer screening and prevention
research at the national level, with a long history of participation in the Alliance for Clinical Trials group. She is
the Deputy Director of the Cancer Control Program and Co-chair of the Prevention committee and has been the
national principal investigator (PI) for four clinical trials, one of which is open and accruing (A212102: A Blinded
Reference Set for Multicancer Early Detection Blood Tests). She is also involved in the newly formed Cancer
Screening Research Network (CSRN), serving on the Clinical Integration Committee for the network. She is a
member of both the NCIs Cancer Prevention Steering Committee and prevention CIRB. Since joining the faculty
of University of Colorado, she has been the medical director of the University of Colorado Cancer Clinic trials
office (CCTO). During this time she has worked with the team to improve accrual, finally seeing a 10% increase
in Q4 of 2024 and significant increase in Q1 of 2025, which if sustained will be a 4 year high in accrual. She has
also assisted in efforts to improve diversity with now over 20% of accruals being from underrepresented groups.
Finally, she has launched a new modality team within the CCTO focused on cancer prevention and survivorship.
However, there remains a critical need to increase accrual to clinical trials, especially among underrepresented
populations, and a significant need for greater focus on cancer screening and prevention trials both locally and
nationally. Dr. Wood proposes a 3-part approach to increasing accrual and diversity though: 1. Increased number
of NCTN trials in the area of cancer prevention and survivorship. 2. Engagement and mentoring of advance
practice providers to act as site PIs for NCTN trials and 3. Bidirectional work with the Cancer Prevention and
Survivorship team and the community outreach and engagement (COE) office to increase community awareness
of trials in the cancer screening and prevention area. She will work towards expanding studies in cancer
screening space focused on the developing area of Multicancer Early Detection (MCED) testing. Support from
the Research Specialist grant will ensure that Dr. Wood has the protected time to support the above efforts. By
focusing in the areas of cancer screening, prevention and survivorship Dr. Wood will not only increase accrual
to NCI funded trials but advance the UCCC goals of performing highly innovative and accessible clinical trials
and advancing health equity and reduce disparities across the continuum from prevention to survivorship.
Support from the Research Specialist grant will ensure that Dr. Wood has the protected time to support the
above efforts.

Public health relevance
Dr. Wood is a leader in cancer screening and prevention research at the national level, with a long history of participation in NCI sponsored clinical trials. Dr. Wood proposes a 3-part approach to increasing accrual and diversity though: 1) Increased number of NCTN trials in the area of cancer prevention and survivorship; 2) Engagement and mentoring of advance practice providers to act as site PIs for NCTN trials; 3) Bidirectional work with the Cancer Prevention and Survivorship team and the community outreach and engagement (COE) office to increase community awareness of trials in the cancer screening and prevention area and she will work towards expanding studies in cancer screening space focused on the developing area of Multicancer Early Detection (MCED) testing. By focusing in the areas of cancer screening, prevention and survivorship Dr. Wood will not only increase accrual to NCI funded trials but advance the UCCC goals of performing highly innovative and accessible clinical trials and advancing health equity and reduce disparities across the continuum from prevention to survivorship